PRENATAL STRESS EFFT. ON ADRENAL CATECHOLAMINES &SUBSEQ. HYPOGLYCEMIA

The purpose of this protocol is to detect and follow defective adrenal responsiveness. Mothers with increased risk factors are recruited. Catecholamines are measured in cord and postnatal blood, and after 10 months following administration of 2- deoxyglucose.